BEHAVIORAL EFFECTS OF ZINC DEFICIENCY IN INFANTS AND TODDLERS

The aim is to identify the behavioral characteristics of mild zinc deficiency in young children, and determine the effects of zinc supplementation on observed behavioral patterns.